Administrative supplement to afferent neurocardiac signals, cue reactivity, and cognitive control

Abstract
This is an application for an Administrative Supplement to an existing R21, NIAAA R21 AA029604 titled
“Afferent neurocardiac signals, cue reactivity, and cognitive control”. Conscious attempts to regulate alcohol
use can be undermined by alcohol cues in the environment that elicit automatic attention and physiological
arousal processes that interrupt behavioral control. We previously discovered that a behavioral form of
neuromodulation, termed ‘resonance paced breathing,’ can alter brain activation during passive viewing of
alcohol cues. The current study measures brain response during active cognitive processing in the context of
alcohol cues and examines whether this form of neuromodulation can be used to reduce cue reactivity and
enhance cognitive control in real time. This Administrative Supplement request is to support our ability to
harmonize data from R21 AA029604 to a common definition, including the creation of new event-related
potential (ERP) data structures, and deposit them in the National Institute on Alcohol Abuse and Alcoholism
Data Archive (NIAAADA). Our ability to devote the needed time and effort to fulfill this requirement for the
parent project will preserve this unique and valuable data resource for the scientific community. The public
health significance of an accessible, brief, and easily trained neuromodulation technique to reduce alcohol cue
salience is great, as cue reactivity and craving are key precipitants of excessive drinking and relapse.

Public health relevance
Narrative The public health significance of an accessible, brief, and easily trained neuromodulation technique to reduce alcohol cue salience is great, as cue reactivity and craving are key precipitants of excessive drinking and relapse. This Administrative Supplement request is to support our ability to harmonize data from R21 AA029604 to a common definition, including the creation of new event-related potential (ERP) data structures, and deposit them in the National Institute on Alcohol Abuse and Alcoholism Data Archive (NIAAADA) to preserve this unique and valuable data resource for the scientific community.